EFFECT OF TIME OF DAY ON SPONTANEOUS GH REPONSE TO AEROBIC EXERCISE

To examine the influence of time of day on the GH and cortisol response to exercise, 10 healthy young men will exercise (lactate threshold) for 30 min. at 3 different times of day (0000, 0700, 1900 h). Subjects will receive a standard meal and then be fasted for 12 h prior to the 6 h sampling period. There will be a control day (no exercise) and an exercise day at all 3 times of day. CORE LAB ONLY.